Plasma Amyloid-beta Peptides, Depression and Alzheimer's Disease in the Homebound

BothAlzheimer'sdisease(AD)anddepressionhavebecomeincreasinglymoreprevalentin thehomeboundelderly,leadingtoincreasedratesofmorbidity,nursinghomeplacementand mortality,thanwhatarefoundinthegeneralelderlypopulation.Ourcross!sectionalstudyofan establishedhomeboundpopulationintheBostonareahasfoundthatlowplasmaamyloid!b42 (Ab42)isassociatedwithdepressionindependentlyofcardiovasculardisease.Wefurther foundthatdepressionwithlowAb42combinedwithhighAb40inplasmaisassociatedwith poormemory.SimilarlyotherresearchstudieshaveshownthatahighplasmaAβ40/Aβ42 ratiosignificantlyincreasedtheriskofAD.MultiplestudiesdemonstratethatplasmaAβ correlateswithcerebralspinalfluid(CSF)Aβwhencognitionisnormal,butthisequilibrium disappearsaftertheADcognitivesymptomsoccur.Wehypothesizetheexistenceofa potentialdepressionsubtypeassociatedwithAbpeptidesinplasma,whichwehavetermed amyloid!associateddepression.ThepurposeofthisR01applicationistovalidatethe existenceofamyloid!associateddepressiondefinedbyahighplasmaAβ40/Aβ42ratio,andto investigatewhetherthisdepressionsubtypeisaprodromaldepressionofAD.Theproposalis basedonourestablishedpopulation,andhastwoaims:Aim1istodocumentmemorydecline prospectivelyinthosewithamyloid!associateddepressionvs.thosewithnon!amyloid depressionvs.thecontrols.Aim2istoinvestigatetherelationshipbetweenplasmaAβand CSFAβ,acentralnervoussystem(CNS)biomarkerofAD,inthedifferentdepression subgroups.Ourlong!termgoalistoidentifyprodromalsignsofADtohelpfacilitateearly treatmentofthediseaseinthehomeboundelderlypopulation.

Public health relevance
The proposed longitudinal study seeks to validate amyloid-associated depression by investigating whether the combination of depression and a high plasma Aβ40/Aβ42 ratio will lead to greater risk of cognitive decline and the finding of the AD biomarkers in CSF as compared to those with a low plasma Aβ40/Aβ42 ratio or those without depression.